Vertical Microbiome Transmission: Implications for Infant Growth

PROJECT SUMMARY / ABSTRACT
Childhood obesity is a rapidly expanding concern, with disproportionate impacts on Latino and Black children.
Across the life course, the gut microbiome has been associated with obesity risk. In children, events like cesarean
section and antibiotic exposure, which alter patterns of vertical microbiome transmission, have been associated
with increased obesity risk. The maternal gut microbiome is remodeled during pregnancy and altered by pre-
pregnancy BMI, impacting the microbes available in the maternal gut microbiome to be vertically transmitted to
the infant. Therefore, Dr. Holzhausen proposes to examine the impact of maternal weight status and preterm
birth on vertical microbiome transmission patterns and childhood overweight and obesity. Dr. Holzhausen will
build upon existing microbiome, metabolome, and phenotype data from two ongoing, longitudinal studies: the
Latino Mother’s Milk Study (L-MMS) and the Atlanta African American Mother Child cohort (AA-MC). In the L-
MMS, Dr. Holzhausen will explore the relationships between maternal weight status, strain-level vertical
transmission of gut microbes, function of the child gut microbiome, and overweight/obesity outcomes in 198
children. Dr. Holzhausen will also perform integrated multi-omics analysis to identify latent subgroups of children
at increased risk for childhood obesity. The AA-MC will serve as a replication cohort to contextualize the
generalizability of initial findings and will further extend the analysis to assess whether vertical transmission
patterns differ by pre- versus non-preterm birth. Through her training, Dr. Holzhausen will advance her
knowledge of techniques to analyze vertical microbiome transmission; gain expertise in metagenomic
sequencing and functional pathway analysis of the gut microbiome; gain experience in techniques for integrating
multi-omics data; and develop an understanding of the socio-cultural aspects of obesity. To gain these skills,
she will complete a multi-faceted training plan incorporating didactic instruction, seminars, extensive hands-on
training, and guidance from a diverse advisory committee of respected researchers. This training will
complement her expertise in 16S rRNA microbiome analysis and bioinformatics, ensuring the successful
establishment of her independent research career. Findings from these studies will improve our understanding
of the role of vertical microbiome transmission in the assembly of the infant gut microbiome and its relationship
with childhood obesity. Because the gut microbiome is a highly plastic metabolic feature, this work has the
potential to lead to the identification of therapeutic targets to prevent childhood obesity. With the proposed study,
Dr. Holzhausen is well positioned to take advantage of existing resources to develop independent,
complementary projects, designed to fill critical gaps in our understanding of the impacts of maternal weight
status and vertical microbiome transmission on the infant gut microbiome that may have far-reaching public
health implications for obesity prevention.

Public health relevance
PROJECT NARRATIVE Childhood obesity is a major public health concern, particularly among Latino and Black children, who experience a disproportionate burden, compared to white children. The proposed research is focused on understanding the impacts of vertical microbiome transmission on childhood overweight and obesity outcomes in Latino and Black populations. Understanding the role that vertical microbiome transmission plays in the development of childhood obesity may have far-reaching public health implications and is critical for developing novel interventions and therapies to prevent childhood obesity.